Targeting Sphingosine Kinase in AML

Little improvement in clinical outcomes has been achieved in acute myeloid leukemia (AML) patients over the past several decades. This is especially true for patients with

Public health relevance
Sphingosine kinase 1 (SphKI) is a sphingoiipid enzyme associated with tumor development as well as tumor's resistance to chemotherapeutic treatment. This study will investigate the potential utilities of novel SphKI inhibitors as anti-cancer agents for acute myeloid leukemia.